Path C Georgia Cooperative Agreement to Implement, improve, and sustain the state Produce Safety Program

Application ID 977350
Grant Number TBD
Georgia Department of Agriculture
The FDA's Cooperative Agreement Program for States and Territories to Implement a
National Produce Safety Program PAR-21-174
Project Period: 2021-2026
Project Abstract:
The Georgia Department of Agriculture, Produce Safety Division strives to improve upon its
development of a produce safety program established under uniform foundation for the regulatory
oversight of Georgia covered produce commodities described in the FSMA produce safety rule. The
development and implementation of this program has historically and will continue to assist federal and
state programs to better direct their regulatory activities toward reducing foodborne illness hazards as
related to growing, harvesting, packing, and holding of produce for human consumption.
Program needs for the cooperative agreement application funding include, but are not limited to:
• Reassess the State of Georgia’s produce landscape, based on established trends, with a focus
upon produce covered under the Produce Rule, and available resources to determine the
necessary size and scope of Georgia’s Produce Safety Program comparatively to previous
requirements.
• Research alternate means to improve and maintain a verified produce farm inventory.
• Provide resources for, and invest in, the GDA program's infrastructure.
• Tailor specific mechanisms to better coordinate with other local, state, territory, and federal
agencies for produce safety activities.
• Formulate a multi-year plan to reinforce and enhance the current produce safety system.
• Refine the current performance measurement system, plan and/or process system to measure
the progress towards the goals of this cooperative agreement using analytical processes
including quantitative and qualitative data.
• Develop and/or provide additional education, outreach, and technical assistance, prioritizing
farming operations covered by the rule.
• Develop and/or provide additional education, outreach, and technical assistance to the
jurisdictional produce safety regulators.
• Refine, audit, and enact a compliance and enforcement program for applicable produce safety
regulations at the jurisdictional level.
If fully funded under this cooperative agreement application as outlined in PAR-21-174, in collaboration
with FDA and State stakeholders as part of a National Integrated Food Safety System, The Georgia
Department of Agriculture, Produce Safety Division will continue progressive efforts toward full
implementation and enforcement of the Produce Safety Rule as we continue to develop, improve, and
perfect our program focused on public health and produce safety.

Public health relevance
Application ID 977350 Grant Number TBD Georgia Department of Agriculture The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program PAR-21-174 Project Period: 2021-2026 Project Narrative: The Georgia Department of Agriculture, Produce Safety Division is currently positioned to regulate and enforce the FSMA Produce Safety Rule as adopted by reference, and this cooperative agreement will continue to provide Georgia with the necessary resources to maintain and improve the robust Produce Safety Program that has been developed effectively to meet the regulations under the Produce Safety Rule over the last five-year CAP Funding Agreement. The Georgia Department of Agriculture Food Safety Division is seeking to continue its efforts in identifying and addressing food safety issues pertinent to fresh produce grown on Georgia farms and packed in Georgia packing shed operations. Through this cooperative agreement, the GDA plans to continue enhancing and improving the safe production of fresh fruits and vegetables in Georgia, and by promoting compliance among Georgia’s agricultural community with regard to the requirements of FDA’s Regulation “Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption” in key areas such as: a) identify potential risks more quickly; b) establish control measures to minimize the growth of pathogenic organisms; and c) increase the ability to rapidly identify foodborne illness and injury hazards, along with improved educational and outreach opportunities for both producers and consumers, create a positive, food-safety conscious change within the state, from farm to table.